Impact of Time-Restricted Feeding in Reducing Cancer Risk Through Optimizing Mitochondria Function

Project Summary
This application, in response to RFA-CA-004 “Research Answers to National Cancer Institute's (NCI)
Provocative Questions (R01 Clinical Trial Optional),” will address “PQ2: How does intermittent fasting
affect cancer incidence, treatment response, or outcome?”
Obesity and age are two major risk factors for cancer development. Thus, therapeutic interventions that
prevent or delay the development of excessive weight gain and/or age-associated physiological dysfunction hold
great promise for reducing cancer risk in the increasingly obese and elderly global population. One such
intervention is time-restricted eating (TRE), a pragmatic form of intermittent fasting in which daily caloric intake
is constrained to a consistent window of 8–12 hours without explicitly reducing total caloric intake. In young male
mice, time-restricted feeding (TRF) reduces cancer risk by preventing obesity and metabolic diseases. TRF has
also been shown to reduce breast cancer xenograft progression in obese mice. In humans, short-term clinical
studies of TRE have revealed metabolic improvements that predict reduced cancer risk, and epidemiological
evidence suggests that prolonged nightly fasting can reduce the risk of cancer, independent of changes in body
weight. This promising preliminary evidence suggests that TRE may be an effective intervention for reducing
cancer risk. However, the effects of TRF in aged animals and in the context of an obesogenic Western diet have
not yet been established, and the mechanisms by which TRF reduces cancer risk remain unknown. This
application builds upon promising preliminary data and leverages the complementary skills of the research team
to address these critical gaps in knowledge. Both obesity and aging are associated with mitochondrial
dysfunction and the production of pro-tumorigenic mitochondrial metabolites. Proposed experiments test the
hypothesis that TRF optimizes mitochondria function through both cell-autonomous and systemic mechanisms,
thereby reducing cancer risk. In Aim 1, the impact of TRF on mitochondria function and related physiologies will
be established in aged mice. Nutrient metabolism, energy consumption, and mitochondria function will be
assessed in these mice. In Aim 2, an innovative combination of metabolomics and mitochondria respiration
assays will be used to test the impact of TRF on mitochondria function in normal and cancer cells (assessing
both cell-autonomous and non-cell-autonomous mechanisms). The effects of TRF on tumor incidence will be
assessed by subjecting tumor-prone mice to TRF. In Aim 3, plasma collected from a recently concluded human
TRE intervention study will be used to test the effect of TRE on mitochondria function and cancer risk in humans.
The proposed comparative analysis of TRE in humans and mice will provide critical mechanistic insight into how
one form of intermittent fasting can help prevent cancer onset and improve treatment outcomes.

Public health relevance
Project Narrative Growing pre-clinical and clinical evidence indicate that fasting for several hours each day can reduce cancer risk, but the mechanisms by which fasting decreases cancer risk are not understood. We propose to use both animal models and human samples to test how daily fasting optimizes mitochondrial function to reduce cancer risk. Since nearly 40% of all men and women will be diagnosed with cancer at some point in their lives, and daily fasting is an easy lifestyle intervention that can be readily adopted by most individuals, the proposed research project is highly relevant to NCI’s mission to reduce the incidence of cancer.